Development of Caspase Cleavage Targeting Chimeras (CACTACs) for Targeted Protein Cleavage.

PROJECT SUMMARY
Caspases are a family of cysteine proteases which can cleave proteins containing cleavage sites on the flexible
region to trigger cell death through apoptosis or pyroptosis. Recently, bifunctional small molecules, such as
proteolysis targeting chimeras (PROTACs), lysosome targeting chimeras (LYTACs), or autophagy targeting
chimeras (AUTACs), have emerged as potential therapeutic modalities by hijacking the ubiquitin-proteasome
system (UPS), lysosome or autophagy to degrade proteins of interest (POIs). Caspase cleavage is a one-step
process that instantly terminate protein function. Here, we discovered that piperlongumine (PL), a dietary natural
product, can recruit caspase(s) to cleave Bcl-xL when conjugated with a Bcl-xL/2 inhibitor ABT263. This finding
motivated us to further develop bifunctional small molecules for targeted protein cleavage by recruiting caspases,
which could be superior to or complementary to the known degraders. We termed this kind of compounds
caspase cleavage targeting chimeras (CACTACs). In this proposal, we will apply a series of state-of-the-art
technologies to find the caspase(s) recruited by the current PL-based Bcl-xL CACTAC and confirm the
mechanism of action. In addition, we will build a Halo-FKBP system to further genetically explore the potential of
CACTAC-mediated targeted protein cleavage by various caspases. The caspase-cleavage site pairs will be
systematically identified to inform the future CACTAC design. We will also further develop new caspase-2
recruiters through PL analog library screening and structure/computer modeling-based optimization. More
CACTACs targeting other POIs will be synthesized and tested to expand the application of CACTACs. The
CACTAC platform proposed here will offer a revolutionary weapon against oncoproteins for cancer therapy.

Public health relevance
PROJECT NARRATIVE We propose a novel approach called caspase cleavage targeting chimera (CACTAC) for targeted protein cleavage by recruiting caspases. Protein function can be abruptly stopped by the one-step, CACTAC-induced protein cleavage. CACTACs that target oncoproteins could be developed as potential cancer therapies.